An inoculation theory-based messaging intervention addressing misinformation about HPV vaccine on social media: The Inoculate for HPV Vaccine randomized controlled trial

Project Summary
Background: Misinformation on social media, or the sharing of false or incomplete information without intent
to cause harm, is contributing to vaccine hesitancy among parents and impeding uptake of the HPV vaccine
among adolescents in the United States. Innovative communication strategies that can be rapidly developed
and deployed to correct evolving misinformation about HPV vaccine on social media and increase uptake of
HPV vaccine are needed. Hypothesis: We hypothesize that theory-based corrective messages directly
addressing the content of misinformation will improve HPV vaccine series initiation and completion as
compared to general corrective messages and a non-message control group. Proposal: We will efficiently
identify recently circulating misinformation on social media using natural language processing (NLP) methods,
develop and test a theory-based corrective messaging tool using a validated message testing protocol, and
assess the efficacy of the tool on increasing HPV vaccine series initiation and completion among adolescents
in an online, block-randomized controlled trial with three arms and longitudinal follow-up. Participants (n=2500)
will be parents of adolescents ages 8-11 recruited from social media and followed up over a 12-month period.
Importance and Innovation: If successful, in addition to improving HPV vaccination uptake, the methods from
this study have the potential to be adapted to address other forms of misinformation swiftly and efficiently in
public health such as that surrounding COVID19, childhood vaccinations, or cancer prevention and treatment
strategies.

Public health relevance
Narrative This project seeks to address misinformation on social media contributing to vaccine hesitancy and low rates of HPV vaccine uptake among adolescents. Achieving the goals of this project has the potential to both improve HPV vaccine uptake in the US and provide replicable methods for rapidly identifying and correcting misinformation surrounding other public health concerns such as COVID19 or childhood vaccinations.